Feasibility Trial of Home-Based Immersive Neurofeedback Self-Regulation Training (INSeRT) for the Preventive Treatment of Pediatric Migraine

Summary. Migraine is a highly prevalent neurological disease in children for which there remains a critical
need for well-accepted, safe and effective preventive treatments to mitigate the progression toward a more
chronic and costly condition. Cortical excitability is hypothesized to play a key role in maintaining the
vulnerability to future migraine attacks. Neurofeedback is a mind-body approach that may facilitate one's ability
to self-regulate cortical reactivity. However, neurofeedback in usual care settings is often difficult for families to
access reliably, and there is a lack of outcome data specifically for pediatric migraine. In preliminary work, we
found that children with migraine responded positively to a neurofeedback-assisted self-regulation treatment
that integrates data from a wearable electroencephalogram (EEG) headband into content viewed on an
immersive virtual reality headset ("Immersive Neurofeedback Self-Regulation Training" - INSeRT). We
hypothesize that using this intervention prospectively from home may be a practical and appealing approach
for children to learn to self-modulate cortical excitability, thereby reducing their vulnerability to future migraine
attacks. The current proposal seeks to further evaluate this idea by means of a pre-efficacy feasibility trial.
Specific aims are: (1) to evaluate and hone the enrollment, retention, randomization, and outcome assessment
procedures planned for a future efficacy trial of the INSeRT intervention, and (2) to determine the feasibility in
children with migraine of completing the INSeRT treatment protocol. During a baseline phase, 38 participants
(ages 10-16 years) diagnosed with migraine will complete patient-reported outcome measures, 4 weeks of
migraine logs, and a lab-based EEG protocol designed to comprehensively evaluate baseline cortical
reactivity. After completion of the baseline phase, participants will be randomized into one of two groups: (a)
Immersive Neurofeedback Self-Regulation Training, or (b) a comparator group that will only view immersive
imagery (without guided relaxation training or neurofeedback). Both groups will receive training on how to
complete the procedures from home, following a schedule of three sessions per week (approximately 8
minutes per session) for a duration of four weeks. Participants will complete outcome measures remotely at
post-treatment and again at a 3-month follow-up timepoint; the lab-based EEG protocol for assessing cortical
reactivity will be repeated at the post-treatment timepoint. The primary trial endpoints comprise metrics related
to intervention feasibility (i.e., treatment adherence, acceptability and tolerability) and trial feasibility (i.e., rates
of enrollment and randomization, retention, and outcome measure completion). These data will inform whether
further testing of this intervention approach is warranted, and if so, how to optimize parameters of the
intervention and study procedures for a future successful efficacy trial. The planned work is significant as it will
enhance our understanding of preventing migraine attacks through mechanism-informed mind-body
treatments, potentially expanding pediatric options for reducing disease progression.

Public health relevance
Project Narrative The proposed research is relevant to public health as it investigates a novel mind-body treatment that may improve outcomes for migraine, one of the most prevalent and disabling conditions affecting both youth and adults worldwide. By exploring strategies to reduce migraine episodes in children, we aim to prevent worsening headaches and disability into adulthood. Successful completion of this project is expected to significantly enhance scientific understanding, clinical management, and reduce the disease burden of childhood-onset migraine